Molecular Oncology Training Grant

DESCRIPTION (provided by applicant): The Molecular Oncology Training Program forms a critical educational activity at the Washington University School of Medicine, Division of Biological and Biomedical Sciences, and Siteman Cancer Center. The program is designed to train graduate and postgraduate students in interdisciplinary research relevant to cancer biology. The goal of the program is to provide basic scientists in-depth training in diverse aspects of basic, translational, and clinical cancer research, and foster the development of interdisciplinary collaborative undertakings. The program includes 28 faculty members in Molecular Oncology. Students participate in the program for 2 yrs each, including laboratory research, a fall journal club course, a fall clinical and translational science mentoring program, a spring didactic cancer biology course, as well as participation in other educational activities including seminars and courses. The Molecular Oncology Training Program builds upon a program funded for 3 years with institutional funds, and will continue to receive partial financial support from the Siteman Cancer Center.